Administrative Core

PROJECT SUMMARY
This proposed U19 project (U19) is to pioneer a comprehensive/novel approach of multidisciplinary integrative
trans-omics analyses of multi-omics data for studying the (epi-)genomic and metagenomic basis of osteoporosis risk
considering both human genome and our second genome – gut microbiome for both males and females, including
the major ethnicity groups, from aspects of both osteoblastogenic and osteoclastogenic lineages at single-cell levels.
To ensure smooth functioning of the U19, this Administrative Core (AC) is necessary, with the Objectives to provide
strong leadership (in research/education/service), productive coordination of interactive and collaborative effort,
effective managerial (personnel/budgetary) support, and efficient facilitation for the overall operation of the U19. The
Core will serve as a synergizer to foster information exchange and collaboration, for individual projects/cores within
the U19, and for U19 investigators with those outside the U19. To be used by all the other U19 components, the
Core will be an integrated part of the research and mentoring activities at our local institutional research center, to
yield efficient and cost-effective use of management and personnel resources.
This core includes Director, Dr. Deng, Associate Directors, Drs. Delafontaine and Shen, all are experienced and
achieved. They together will furnish strong administrative, management and leadership capabilities for ensuring
smooth functioning and maximum productivity of the U19, through the following activities:
· Delivering competent and timely administrative services
· Coordinating the efforts of the U19 projects, cores, and personnel
· Strengthening dialogue with NIH officers and scientists, enhancing collaborative relationship with the Internal and
External Advisory Boards and with colleagues across departments and institutions
· Providing quality control of ongoing research & independent in-/ex-ternal evaluation of progress and productivity
· Extending the benefits of U19 participation to mentoring of junior faculty, postdoctoral fellows, and students with
diversity and inclusion
· Coordinating scientific lectures and interactive presentations locally and at national/international levels
· Organizing research/education activities/meetings, including symposiums significant to the U19 research theme
· Providing support for, e.g., budgetary planning and review, preparation of grant reports and manuscripts
· Assuring compliance with leadership expectations, governmental policies and institutional directives
· Coordinating implementation of the U19 and other local/NIH funded projects
· Providing and monitoring within-/outside-U19 data sharing for facilitation of research and data mining
· Promote team science approaches in problem solving in core services
The use of the Core services will be, subject to fine-tunes in practice, largely determined by 1) the need of the
other individual projects/cores as deemed relevant to the Core’s Objectives and Specific Aims, and 2) coordination
of the Directors with other U19 U19 investigators. The quality of the Core services will be measured and continuously
improved upon user feedback, self-review/evaluation, and independent evaluation and recommendations from the
In-/Ex-ternal Advisory Boards, if necessary.